OBESITY, INSULIN RESISTANCE, IGF'S, AND BREAST CANCER RISK IN AFRICAN AMERICANS

This subproject is one of many research subprojects utilizing the resources provided by a Center grant funded by NIH/NCRR. The subproject and investigator (PI) may have received primary funding from another NIH source, and thus could be represented in other CRISP entries. The institution listed is for the Center, which is not necessarily the institution for the investigator. The purpose of this study is to better understand how lifestyle factors and their interaction with genetic factors influence a women's risk of developping breast cancer. In order to learn more about the causes of breast cancer, we need to compare the lifestyles of people who have breast cancer with those who do not. 600 women are expected to be enrolled.